Species-Specific Epigenetic Basis of Zebrafish Inner Ear Hair Cell Regeneration

PROJECT SUMMARY/ABSTRACT
The major cause of hearing loss is damage to the inner ear cochlear hair cells. One potential strategy to
regenerate hair cells and restore hearing is to induce the transdifferentiation of surrounding supporting cells into
new functional hair cells. This is based on the observation that non-mammalian vertebrates such as zebrafish
can replenish sensory hair cells throughout life from these neighboring supporting cells. However, the fact that
mature mammalian supporting cells lose the ability to transdifferentiate into hair cells poses a great challenge to
implement this strategy in the clinics to restore hearing in patients.
Our lab recently identified an epigenetic mechanism that restricts mouse supporting cell plasticity by permanent
closing of chromatin around enhancers driving expression of hair cell genes, including critical transcription factors
such as ATOH1 and POU4F3. ATOH1 is a master regulator that drives the differentiation of hair cells across
vertebrates, with the inability to upregulate Atoh1 expression in postnatal mouse supporting cells being a key
barrier to hair cell regeneration following injury.
In this proposal, I investigate how the highly regenerative zebrafish may escape such epigenetic repression by
examining chromatin accessibility near zebrafish hair cell genes. My preliminary single-nuclei ATAC sequencing
data reveal that several potential regulatory elements of zebrafish atoh1a remain accessible in supporting cells.
This is in contrast with what we observe at the mouse Atoh1 locus. Interestingly, this maintenance of chromatin
accessibility is specific to the atoh1a locus, as pou4f3 and other hair cell genes do not retain chromatin
accessibility in zebrafish supporting cells. This suggests that sequence-specific features of the atoh1a locus,
rather than general chromatin modifying enzymes, may account for this maintenance of accessibility in zebrafish
supporting cells. I hypothesize that intrinsic properties of the zebrafish atoh1a locus maintain accessibility of its
cis-regulatory elements, which facilitate its upregulation during hair cell regeneration.
In Aim 1, I test whether sequence differences between zebrafish and mouse atoh1a/Atoh1 loci account for the
fish-specific ability to maintain open chromatin. In Aim 2, I test a class of atoh1a enhancers that remain
accessible in supporting cells for their requirement for continued hair cell generation. I also test the role of a
second class of supporting cell-specific atoh1a elements in preventing ectopic hair cell formation from supporting
cells in the absence of injury. By learning how zebrafish maintain atoh1a locus in a poised state in adult
supporting cells, results from these aims will guide future endeavors to regenerate hair cells and restore hearing.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Hearing impairment affects over 30 million Americans and can significantly impact their day-to-day life. There are currently no regenerative approaches available in the clinics to reverse hearing loss in the human inner ear. By comparing the regeneration potential in the inner ear between a highly regenerative versus a non- regenerative animal model, this proposed research will identify potential elements from the regenerative species to inform new therapeutic strategies to restore hearing in humans.